Administrative Core for Institution # 269291

SUMMARY
The main objective of the Central Administrative and Management Core (CAMC) is to serve as the anchor and
to provide administrative oversight for the Comprehensive NeuroHIV Center (CNHC) at Temple University and
Drexel University in Philadelphia. The overall objective is to improve and expand research related to neuroHIV
and neurological diseases associated with viral infection of the CNS including neurobehavioral impairment and
mental disorders. The infrastructure created by the CNHC during the last 10 years offers unique expertise to
local, regional, and national neuroHIV investigators with focus on our strengths of gene editing and delivery,
mammalian progenitor cells and iPSC cultures, assist investigators with genetic analysis of virus-infected cells
before and after editing procedures, and support for a full-range of state-of-the-art microscopic and imaging
analysis. At the same time, the CNHC will coordinate the NeuroHIV Community Partnership and Disparity Core
affecting PWH, the newly developed core that is now included in our program. The CAMC will assist with liaising
with current and potential community partners in fostering synergy among the patient population and the
participant researchers. Tkhe Center offers its unique expertise in functional cellular assays including
microelectrode array assay to study neuronal cell behavior in response to external stress. Furthermore, the
Center will enable investigators to initiate clinical and neurobehavioral examination with a well-established cohort
of people with HIV (PWH) longitudinally examined at Drexel University College of Medicine. The CAMC will
provide the infrastructure for coordinating and overseeing all activities of the CNHC and facilitating synergistic
interaction among the cores and other NIMH-supported Centers. The CAMC will delineate the strategic plan,
identify short- and long-term objectives, execute detailed plans to be implemented, carry out internal and external
reviews and assessment tools based on established criteria to ensure productive and efficient use of resources
to achieve the overall objectives of the CNHC. It will also offer biostatistical support for data analysis and
interpretation obtained from the basic science and clinical cores. In addition, this Core will coordinate with the
Scientific Cores to disseminate information to the participants as well as Core users, recruit Core users, solicitate
pilot applications, catalogue all original data generated by the Cores, facilitate and track all material distributed
by the Cores, including, but not limited to, cell lines, viral stocks, and clinical specimens.